Technology to Empower Changes in Health (TECH) Network Participant Technologies Center

Abstract/Project Summary
Remarkable advancements in our nation's digital infrastructure combined with explosive growth
in pervasive wireless connectivity have created the unprecedented potential to improve both our
health and the delivery of healthcare. Beyond their universal availability, smartphones and the
mobile networks that support them offer an unparalleled platform for health-related data
acquisition and communications. The visionary Precision Medicine Initiative Cohort Program
(PMI-CP) is possible, in large part, due to the availability of this digital infrastructure. However,
to convert the enormous pool of mostly disjointed information available through a million-person
longitudinal cohort into meaningful, life-changing medical knowledge requires development of
an innovative, member-centric, engaging, and secure digital network that is state-of-art today,
and by design, sustainably so over ensuing years and decades.
In order to assure that the PMI-CP achieves its goal to transform the existing culture of medical
practice and research by empowering patients, researchers and providers to work together as
peers requires the collaborative support of many people with diverse expertise but a singular
focus on participant-centeredness. The Participant Technologies Center (PTC) is a critical
component to making that happen, and to ensure that we are able to successfully meet the
needs of the PMI Steering Committee, and most importantly, the PMI participants, we have
formed a network or world-class partners that together have the resources, experience and
capabilities necessary to expertly address the known and not-yet known challenges of an
endeavor as transformational and far-sighted as the PMI-CP. The Technology to Empower
Change in Health (TECH) network is led by Scripps Translational Science Institute and Sage
Bionetworks, and includes PatientsLikeMe, Qualcomm, Walgreens, Verizon, Lockheed-Martin,
and the Blue Cross Blue Shield Association, bringing together unprecedented experience and
knowledge around participant engagement, digital security and personal technologies.
Although the PTC is designed to optimize the utilization of technologies in the PMI-CP, our
unwavering focus will be on the PMI participant and how to maximize the benefit of participation
for them personally. We will accomplish this by laying a foundation built upon personalized
engagement strategies, an resolute commitment to security and privacy, and assuring the
availability of the state-of-the-art technology needed to meet all current and future data and
information sharing needs.
.

Public health relevance
Narrative The Technology to Empower Change in Health (TECH) Network's Participant Technologies Center will work closely with the PMI steering committee and the study participants to development an innovative, member-centric, engaging, and secure digital network that is state- of-art today, and by design, sustainably so over ensuing years and decades.